Childrens' of Mississippi Neonatal Research Group

This application strongly supports the Mississippi state's only academic Level IV newborn facility, the
Children's of Mississippi Newborn Intensive Care Unit (NICU) at the University of Mississippi Medical Center
(UMMC)'s candidacy as a clinical center by the NICHD Neonatal Research Network (NRN). We work to
improve the life of Mississippi children by providing exceptional patient care, training the next generation of
healthcare providers, and engaging in innovative research to achieve the vision of UMMC to improve
Mississippian's health outcomes and eliminate health care disparities. Researchers in the newborn division are
contributing by performing innovative, definitive, rigorous, and reproducible translation, single and multi-site
clinical, and community interventions research focused on improving newborn health to reduce the gap
between “bench to bedside to countryside” research.
The newborn center at the UMMC is exceptionally well positioned to be selected for the following reasons. 1)
We serve a very high-risk and underserved population, the majority with low socioeconomic status and public
insurance from urban and rural areas with high representation of racial/ethnic minorities facing health
disparities. 2) Mississippi has some of the highest rates of maternal hypertension, preeclampsia, obesity,
metabolic disorders, preterm birth, low birth weight, and congenitally linked behavioral disorders, such as
autism in the USA. 3) The Center for Maternal and Fetal Care at UMMC, the only quaternary center for
advanced fetal care in the state, manages around 3,000 deliveries each year, of which 75% are considered
high risk. 4) About 1000 NICU admissions per year, of which almost 160 are born less than 29 weeks of
gestation, and about 70% are inborn. 5) The Division of Newborn Medicine has a well-organized clinical
research infrastructure with a successful track record of participation in multi-center NIH, industry-sponsored,
and investigator-initiated clinical trials in newborns. 6) The Division has consistently been the highest study
subject recruiting site in many multi-center clinical trials. This success is attributable to the strong research
culture and a unique system of round-the-clock availability of dedicated research coordinators, including after-
hours and weekends. This is an exceptional strength of our program. 7) The institution maintains a long-
standing multidisciplinary Newborn Follow-up Program that serves the entire state. 8) The Division of Newborn
Medicine has consistently received Institutional support. It has a long-standing history of collaboration with
other institutional centers/departments with NIH-funded programs.
If selected, we will be fully committed to participating in all Network studies unless they do not have the
relevant eligible population. We agree to prioritize Network studies over other studies, including other NIH-
funded studies, for subject recruitment at our center.

Public health relevance
Our NICU and Division of Newborn is well positioned to be selected as a clinical center in NRN because of High-risk population of diverse racial and ethnic from state with well-described health disparities A strong infrastructure base, experienced research team, and a strong culture of research